Investigating the Role of Transcription Factor Snail1 in Astyanax mexicanus Heart Regeneration

Investigating the Role of Transcription Factor Snail1 in Astyanax mexicanus Heart Regeneration
(7) PROJECT SUMMARY/ABSTRACT
With heart disease consistently being the leading cause of death globally each year, exploring heart
regeneration across models has been a promising avenue for revealing how these abilities were evolutionarily
gained or lost. Astyanax mexicanus provides a rare intra-species comparison of rapid heart regeneration loss
between two morphotypes that diverged as recently as 20,000 years ago. While the river-dwelling surface fish
fully regenerate amputated heart tissue within 64 days, the cavefish develop a permanent fibrotic scar with no
tissue replacement. The transcription factor snai1b was found to be upregulated in cavefish compared to
surface fish hearts in bulk RNA sequencing data. An upregulation of Snail post-heart injury was associated
with increased fibrosis and decreased cardiac function in mice, where the Snail locus was labeled with histone
lactylation, an epigenetic modification that correlates with open chromatin in migrating cells. Variable food and
oxygen availability between the isolated caves and open river habitats caused a metabolic divergence, with
cavefish preferring glycolysis over oxidative phosphorylation (OXPHOS). A similar shift in preference from
OXPHOS to glycolysis occurs in migratory stem cells during epithelial-to-mesenchymal transition (EMT). This
shift increases lactate and consequently lactylation of EMT-related genes, including snail. After migration, cells
undergo a mesenchymal-to-epithelial transition (MET) to reintegrate into the repaired tissue. However, since
both OXPHOS and glycolysis decrease in cavefish upon injury, snail levels may remain elevated and MET may
not occur. I hypothesize that intrinsically raised glycolysis in cavefish leads to the lactylation and activation of
snail, increasing fibrosis and EMT without MET after heart injury. This interdisciplinary approach will combine
studies of metabolism, gene regulation, and morphogenesis to understand the ability to regenerate cardiac
tissue. Aim 1 will spatially survey glycolysis and OXPHOS post-ventricular amputation through
immunohistochemistry (IHC), then pharmacologically target these processes and observe the effects on
regeneration. Aim 2 will utilize IHC, ATAC sequencing, and CUT&RUN to characterize lactylation and gene
regulation in injured cave and surface fish hearts, followed by inhibition or induction of lactylation and
evaluation of regeneration. Aim 3 centers on tracking EMT via IHC and using chemical inhibitors to suppress
EMT and encourage MET to assess their roles in A. mexicanus cardiac regeneration. This project aims to
uncover why some vertebrates can regenerate their hearts while others cannot. By comparing metabolic shifts,
gene regulation, and EMT following injury within the same species, I will examine the role of the transcription
factor Snail in driving differential heart regeneration abilities, and uncover potential treatments to recapitulate
regenerative phenotypes in a non-regenerative animal. Support from the F31 will enable me to not develop
technical skills such as confocal microscopy, pharmacological trials, and bioinformatics, but will also provide
me with opportunities to participate in international conferences and share my findings with the community.

Public health relevance
(8) PROJECT NARRATIVE Comparisons between cave and surface populations of Astyanax mexicanus have provided great avenues for researching the rapid evolutionary divergence of many traits, including metabolic responses to differing food and oxygen availability as well as the loss of heart regeneration abilities. This project explores the link between their metabolic and regenerative differences through the regulation of the epithelial-to-mesenchymal transition (EMT) transcription factor, Snail, which was found to be upregulated in the non-regenerative cavefish. In this study, I will be assaying A. mexicanus’ metabolism, snail gene regulation, and EMT responses to ventricular amputation to identify the underlying cause of retention or loss of heart regeneration abilities.